Understanding the Importance of Industry Relationships for Cancer Care Quality, Outcomes, and Costs

PROJECT SUMMARY
Personal payments from the pharmaceutical industry to US physicians are common and influence physician
prescribing. Approximately 80% of medical oncologists receive personal payments from industry each year,
with a mean of over $5,500 per physician. These payments may result in differences in the quality of cancer
care delivery and potentially affect patient outcomes. Because the selection of different cancer treatments
directly impacts patient outcomes such as drug toxicity, financial toxicity, and survival, these outcomes may be
affected when industry payments cause changes in physicians’ treatment selection. Despite concerns about
the potential influence of industry payments on medical practice, no study has investigated whether the
changes in treatment patterns resulting from industry payments have consequences for patients. The short-
term project goal is to evaluate the association between industry payments and cancer care quality, patient
outcomes, and costs. The long-term research goal is to understand the importance of physician-industry
financial relationships within the US healthcare system. Our overall hypothesis is that industry payments affect
care delivery and, ultimately, patient outcomes. To test this hypothesis, we will link CMS Open Payments data
to Medicare fee-for-service claims. The exposure of interest will be receipt of payments by the treating
physician from a manufacturer of a drug relevant to each patient’s treatment decision. Aim 1: Assess the
association between industry payments and cancer care quality. We will assess whether receipt of
industry payments by physicians is associated with the likelihood that they deliver the guideline-preferred
treatment for each patient (1A) and established forms of low-value care (1B). We hypothesize that physicians
who received payments are less likely to use guideline-preferred treatments (1A) and are more likely to use
low-value interventions (1B). Aim 2: Assess the association between industry payments and patient
outcomes and costs of care. We will assess whether patients treated by physicians who received industry
payments have differences in patient-focused outcomes such as unplanned acute care utilization, survival
time, and quality of end-of-life care (2A) and whether they have differences in Medicare spending (2B). We
hypothesize that patients treated by physicians who received payments are more likely to have acute care
utilization, shorter survival time, and lower quality end-of-life care (2A) and to have increased Medicare
spending (2B). This study will be the first to assess the relationship between industry payments and patient-
focused outcomes, substantially increasing our understanding of the health system impact of these payments.
These results may inform future policy and practice decisions regarding physician-industry interactions,
potentially contributing to improvements in cancer care quality, improved patient outcomes, and lower costs.

Public health relevance
PROJECT NARRATIVE Personal payments from the pharmaceutical industry influence physician prescribing, but little is known about whether these payments affect patients. This study proposes to evaluate the association between industry payments to physicians and the quality, patient outcomes, and costs of cancer care.